PDX/Biospecimen Core

PROJECT SUMMARY/ABSTRACT
Summary: Core B provides part of the infrastructure support for Projects 1 - 3. It has been
designed to meet the needs of these projects and serve as a stand-alone resource for
collaborative efforts with others. This Core will provide a well-organized and standardized system
of specimen collection, storage, distribution and related clinical/research information
dissemination that is based on over two decades of experience. There will be consistency and
quality assurance in the pathological analysis of tissue specimens. This Core has 5 components:
1. Maintain and Distribute Patient-Derived Prostate Cancer PDX models
2. Collect and Distribute Biospecimens
3. Establish and Maintain Specimen Quality and Core B Service Efficiency Programs
4. Provide Specialized Pathology and Laboratory Services
5. Administrative Program to prioritize the distribution of specimens, ensure patient
confidentiality and compliance with IRB requirements, continually improve quality control
measures and interact with other researchers.
Specimens of LuCaP series of prostate cancer xenografts from our repository have been and will
continue to be distributed to P01 projects and to other prostate cancer investigators on an
international basis.
Relevance: The performance of translational research mandates that investigators have ready
access to well documented clinical specimens and relevant biological models. Core B directors
have decades of experience in recognizing these needs and providing such services not only to
local investigators but to those who request specimens on a world-wide basis. These interactions
will continue and will truly enhance the translational aspects of the P01.

Public health relevance
PROJECT NARRATIVE The performance of translational research mandates that investigators have ready access to well documented clinical specimens and relevant biological models. Core B directors have decades of experience in recognizing these needs and providing such services not only to local investigators but to those who request specimens on a world-wide basis. The Core B will continue to make these resources available to the PO1 projects and other investigators.